Innovative Analytical Methods for DNA Methylation Age

Project Summary/Abstract
As the US population continues to age in the coming years, the need for biological measures and biomarkers of
aging becomes increasingly urgent. Finding and validating biomarkers of aging continues to attract research
efforts, but with limited success.
Epigenetic modifications are potentially critical to the biological processes that underlie aging (Ben-Avraham et
al. 2012). More recently, DNA methylation levels (DNAm) have been identified as useful tools for defining
biological age, as Hannum et al. (2013) and Horvath (2013) both combined DNAm at multiple loci to quantify
human aging. This “DNA methylation age” predicted all-cause mortality later in life (Marioni et al. 2015).
Both Hannum and Horvath applied the ultra-high dimensional (~485K DNA methylation markers) variable
selection methodology with elastic net penalty (Zou and Hastie 2005) to derive their epigenetic age indices.
However, there are several issues in the original approaches by these researchers. In this grant, we propose
more accurate and robust epigenetic age models using ultra-high dimensional DNA methylation markers. We
also consider longitudinal DNAm data. We will develop and disseminate a user-friendly statistical software
package that will enable researchers to implement these methods with ease. We will apply our methods to two
large longitudinal cohort studies: the Coronary Artery Risk Development in Young Adults (CARDIA) and Multi-
Ethnic Study of Atherosclerosis (MESA).
Our discoveries may illustrate the biological mechanisms underlying traditional and innovative risk factors for
mortality and discover more accurate and reliable markers for biological aging. Potential clinical, lifestyle, and
pharmaceutical interventions can thus be developed for healthy aging.

Public health relevance
Project Narrative Aging has emerged as a major public health issue in the US, which necessitates the need for identifying biological measures and biomarkers of aging and age-related chronic diseases. More recently, DNA methylation has been identified as a useful tool for defining biological age. However, there are several issues in the existing approaches. We propose more accurate and robust epigenetic models to identify ultra-high dimensional DNA methylation markers to predict chronological age.